Johns Hopkins-Tufts Trial Innovation Center HEAL Pain ERN Supplement

ABSTRACT OF THE FUNDED PARENT AWARD
The JHU-Tufts Trial Innovation Center (TIC) is an established, functioning team of
multisite trial PIs, experienced lead managers, administrators, and scientists at both
Johns Hopkins University (JHU) and Tufts University (including its longstanding
partners, the Harvard Clinical Research Institute (HCRI) and Massachusetts Institute of
Technology (MIT)). BIOS, a JHU trials research group, will operationally convene this
group and provide staff to execute the required TIC program and its specific tasks. Our
joint expertise, developing new methods for multicenter trials, will be provided to the TIC
program whereby individual TIC trials will be executed with excellence and innovations
incorporated into subsequent trials. This proposal is derived from our established track
record of neuroscience and Alzheimer’s and other dementia trial execution
accomplishments and innovations, which will facilitate progress towards the NCATS
goal of producing three robust TICs to speed translational research. We will Develop,
Demonstrate, and Disseminate an integrated, coordinated, multistakeholder TIC
process to improve the efficiency and quality of multi-site trial initiation and subsequent
execution by sites. The JHU-Tufts TIC will leverage operational service expertise in
geriatrics, diseases of aging and Alzheimer’s disease for CTSA trials implementation to
study novel operational innovations. The scientific purpose of our team’s efforts will be
to demonstrate that TIC innovations in trial design, execution, and evaluation will lead to
better trial performance, including faster start-up, faster completion, and greater protocol
compliance for all NCATS program trials and be applicable to Alzheimer’s and other
aging trials. We will measure benefits using explicit efficiency and quality-focused
metrics to test these innovations. We will disseminate results of valid CTSA-TIC
innovations produced from all consortia trials to current clinical trial teams and research
trainees. We hope to collaborate with NCATS to produce a platform that allows
investigators to perform trials faster and at a higher quality.

Public health relevance
NARRATIVE The NIH has created the Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. Trials will be conducted through the NIH HEAL Pain Management Effectiveness Research Network (HEAL Pain ERN), which will use the infrastructure of the NCATS Trial Innovation Network to provide scientific guidance and coordination of the HEAL Pain ERN Trials. Three Trial Innovation Centers (TICs) will provide integrated functions for the clinical coordinating center, data coordinating center, and Biostatistics Core. The Johns Hopkins/Tufts TIC will serve as the Biostatistics Core.